Improving Speed and Cost of Entry for Holographic Optogenetics

PROJECT SUMMARY/ABSTRACT
Mapping the neural networks in the human brain will help researchers shed light on neurological diseases such
as Alzheimer’s and Schizophrenia, as well as the workings of memory, vision, and consciousness. When first
demonstrated over 15 years ago, holographic photostimulation of 3D populations of neurons represented a
transformative innovation in the way that functional brain mapping was conducted in neuroscience. In this
approach, neuroscientists use Spatial Light Modulators (SLMs) to holographically project points of light into living
brains. Photostimulating precisely targeted neuronal ensembles in this way more closely mimics natural brain
activity to significantly improve functional mapping capabilties. Through the hard work of early holographic
neuroscience trailblazers and SLM manufacturers, this approach has now become widely adopted.
Now through the combination of fast voltage indicators and opsins, high-speed SLMs, efficient data analysis,
and rapid data pipelines, neuroscientists are pushing toward the goal of performing closed-loop experiments,
wherein the optical control system can intervene in real-time in response to observed neural activity or behavior.
Closing the loop and enabling activity-guided control of neural circuit dynamics will provide neuroscientists a
powerful new tool to establish causal relationships in circuit architecture and tune optogenetic interventions for
optimum response. To realize this goal, SLMs need to not only provide sub-millisecond liquid crystal
response, but also a fast data pipeline that doesn’t rely on pre-calculated and stored data.
In our prior work, we have demonstrated that such capabilities are technically achievable, however current
solutions are not commercially viable due to prohibitively high costs and supply chain limitations. The proposed
work will develop new SLM hardware and firmware to address these requirements, while leveraging a new
modular architecture to provide cost-effective SLMs that will be affordable to the neuroscience community.

Public health relevance
PROJECT NARRATIVE Mapping the neural networks in the human brain will help researchers shed light on neurological diseases such as Alzheimer’s, as well as the workings of memory, vision, and consciousness. Stimulating neurons with holographically steered laser beams is a leading method for studying large-scale neural networks, but requires specialized spatial light modulators to do the high-speed holographic steering. This project aims to develop high- speed spatial light modulators that can better simulate natural brain activity at a price that will make them accessible to more neuroscience researchers.